The Lymphatic Forum 2025

Summary
The Lymphatic Forum 2025 (LF2025) will be the 5th iteration of a planned conference series that brings together
researchers from around the world who study lymphatics in health and disease. The lymphatic system is a
relatively understudied, yet vital component of the cardiovascular system that couples the tissue parenchyma to
the venous blood via lymph flow through a complex network of lymphatic vessels. It transports fluid,
macromolecules, lipids, tissue catabolic products, and immune cells/agents as lymph. Thus, the lymphatic
system provides critical links for the transport of fluid, macromolecules, cells, and other elements from the
interstitial space of all organs to and through numerous lymph nodes to the venous blood. In completing this
transport, it regulates body fluid volume, macromolecular homeostasis, immune function, inflammation, and lipid
absorption/metabolism. It is a specialized vascular system with a complex network of low-pressure vessels with
unique mechanisms to form and transport lymph. The lymphatic system serves as both a complex network of
lymph conduits and as a series of unique intrinsic lymph pumps that generate and regulate the lymph flow that
drives all of its functions. Because of its unique, complex structural and functional characteristics, it has been
difficult to examine and quantify its structure and function in the body. However, a better understanding of its
structure and function is important to health and disease. Other international/national lymphatic biology
conferences, including the previous Lymphatic Forum 2017, 2019, 2021 (Virtual), and 2023 focused
predominantly on embryologic development, lymphangiogenesis, lymphatic endothelial cell function, and
relationships to cancer and immunity. The conference plan outlined in this application is unique in that it is the
first that has a significant focus on disease-oriented sessions on the lymphatic system, including lymphatic
disease detection, tumor lymphatics and lymph node metastasis, therapeutic innovations, and clinical trials.
Presentations and discussions will focus on the molecular regulation of the lymphatic system in health and
disease, exploring new insight into its contribution to pathological processes. Additionally, the conference will
also include a plenary session on unsolved issues and gaps in lymphatic disease with a panel discussion. The
lymphatic system is an intrinsic, understudied part of the cardiovascular and immune systems that influences
health and disease. The goal of LF2025 is thus highly relevant to the missions of the NHLBI which has accepted
primary assignment on this application, and also of the NIDDK, NIAID, and NCI, which will be asked for
secondary support. Additionally, the conference is specifically designed such that trainees and young
investigators have significant roles.

Public health relevance
Narrative The Lymphatic Forum 2025 is the 5th iteration of a planned conference series that brings together established and young researchers from around the world who study lymphatics in health and disease. The lymphatic vascular system is a relatively understudied, yet vital component of the cardiovascular system that couples the tissue parenchyma to the blood via lymph flow through a complex vascular network. The conference plan pays particular attention to young investigators and focuses on complex aspects of the lymphatic system such as biomechanics of lymphatic structure and function, lymphatic development, growth and remodeling, mechanisms of lymph flow generation and regulation as they apply to bodily organs and their functions, tumor-associated lymphatic and lymph node metastasis, and the relationships between the lymphatic and immune systems and inflammation regulations as it pertains to pathologies associated with these specific organs.